EFCY OF MIACALCIN NASAL SPRAY IN THE TREATMENT OF STEROID-INDUCED OSTEOPOROSIS

The purpose of this study is to evaluate two doses of intranasal salmon calcitonin versus placebo in patients with known steroid-induced osteoporosis.